Assessing the Long-term Impact of COVID-induced Telemedicine Expansion on Dementia Care

Project Summary Abstract
A dramatic long-term effect of the COVID-19 pandemic is the expanded use of video- and phone-based
telemedicine in routine primary care. The pandemic caused primary care practices to severely limit in-person
visits and shift to telemedicine visits, but over time use of this modality of care as an option alongside in-person
care is persisting. The implications are particularly significant for the more than 5 million people with dementia
(PWD) and their caregivers. High-quality primary care for PWD requires addressing complex clinical, social, and
behavioral dimensions of health. While some of these dimensions may be facilitated by telemedicine, the degree
to which PWDs use and benefit from telemedicine is unknown. On the one hand, telemedicine may result in
more timely primary care as this modality allows PWD to avoid the need to travel, which is particularly challenging
for this population. However, during telemedicine encounters, primary care providers (PCPs) face limited ability
to assess movement and functional status, loss of communication nuances, and potentially reduced ability or
willingness of PWD and caregivers to share information. Such limitations could result in poorer quality of care,
including higher likelihood of subsequent utilization of in-person care (e.g., ED visits). Assessing which PWD use
telemedicine and the relationships between visit modality (video, phone, in-person) and outcomes (timeliness of
care and subsequent utilization patterns) will reveal the benefits and the shortcomings from primary care use of
telemedicine in the care of PWD.
We propose a sequential mixed-methods study that will generate robust evidence characterizing which PWDs
use telemedicine, and the relationships between use of telemedicine and outcomes (timeliness and subsequent
utilization), in the primary care setting. We will draw on data from two large health systems: Kaiser Permanente
Northern CA (KPNC) - a telemedicine pioneer - and UCSF Health - a nationally-recognized dementia care
provider. We will use these results, alongside a literature review, to engage a national expert panel in
brainstorming potential strategies to adapt the use of telemedicine to better support dementia care in the primary
care setting. Finally, we will conduct a PCP survey to rate the feasibility and impact of the strategies. Ultimately,
our results will directly inform the decisions facing primary care practices across the nation about ongoing
investment in telemedicine and how to optimize it in ways that serve the growing dementia population.

Public health relevance
PROJECT NARRATIVE A dramatic long-term effect of the COVID-19 pandemic is the expanded role of telemedicine integrated into primary care, which is particularly significant for the more than 5 million people with dementia (PWD) and their caregivers given the multi-faceted dimensions of clinical, social, and behavioral assessment and care for dementia in the primary care setting. Drawing on data from two diverse health systems, UCSF Health and Kaiser Permanente Northern CA, this project will study the implications of the COVID-induced expansion of telemedicine across varied dimensions for PWD including equity of use, timeliness of care, and subsequent near-term utilization. These findings, alongside insights from the broader literature, will be used to identify strategies to tailor telemedicine use in primary care to better meet the needs of PWD.